Investigating virulence functions of mastitis-associated Extraintestinal pathogenic Escherichia coli relevant to human disease

Abstract/Project Summary
Extraintestinal Escherichia coli (ExPEC) are bacteria that live in the intestines of mammals and cause life-
threatening illnesses when they infect other tissues. The societal burden due to this group of pathogens is vast
and growing, in part because of increasing antibiotic resistance and a lack of vaccination options. Urosepsis,
pneumonia and neonatal meningitis are human diseases caused by these strains. Our long-term goal is to
understand the molecular mechanisms of pathogenesis of ExPEC that circulate in animals and humans. Many
animals are susceptible to these pathogens and represent reservoirs for human infection. The central
hypothesis of this application, based on substantial preliminary data, is that some mastitis strains of bovine
origin also have the potential to cause disease in multiple hosts including humans. This is a novel finding,
based on evidence that includes genetic similarities with human ExPEC lineages, virulence in Galleria
mellonella infections, resistance to human serum, and the ability to cause sepsis and urinary tract infections in
mice. The objective of this work is to characterize virulence factors that allow some mastitis-associated strains
to infect multiple hosts and cause extraintestinal disease. A genome-wide screen for mastitis strain M12
virulence factors led to the discovery of a cluster of capsule biosynthesis genes encoding a Group 3 capsule.
Group 3 capsules are present in many ExPEC strains, but their roles are not well defined. An unencapsulated
mutant strain was unable to infect spleens or kidneys of mice. Additional mastitis-associated strains in our
collection also encode Group 3 capsules, which may promote virulence by helping these bacteria avoid
neutrophil phagocytosis. Neutrophils are critically important for defense against many bacterial pathogens
including ExPEC, but we do not fully comprehend the mechanisms whereby ExPEC resist being engulfed or
killed by these cells. The objectives of this proposal will be accomplished with three specific aims: (1)
Estimate the fraction of mastitis-associated E. coli that can cause disease in established models of human
ExPEC infection. We will utilize novel DNA barcoding strategies to measure competitive fitness of multiple
strains in these experiments. (2) Characterize the role of Group 3 capsules found in mastitis-associated strains
in conditions relevant to human disease. We will test whether these capsules promote resistance to killing by
neutrophils or serum and during experimental infections. (3) Identify all of the genes that are needed for
production of the M12 Group 3 capsule, including those both inside and outside the capsule locus. Since
building the capsule is a critical virulence function, this could identify targets for new therapies. This proposal
is innovative because it is based on the novel concept that mastitis-associated strains are potential human
pathogens. It is significant because it will provide greater understanding of the molecular basis for ExPEC
virulence in multiple hosts, and the relationships between ExPEC found in different environments. These
findings may inform new ways to prevent disease caused by these bacteria and improve public health.

Public health relevance
Relevance to Public Health Extraintestinal Escherichia coli cause a wide range of serious human diseases, and many of these bacteria come from animals or food products. This project will investigate whether strains that cause mastitis also belong to this group of pathogens and will identify genes that enable these bacteria to infect multiple species. This could lead to better methods to identify dangerous strains and interfere with their ability to cause infection.